Public Use Data on Mexican and Central American Immigration

PROJECT SUMMARY
This proposal requests funding for the Mesoamerican Migration Project to gather and disseminate high quality
data on authorized and unauthorized migration to the U.S. from Mexico, El Salvador, Guatemala and
Honduras. The first two decades of the twenty-first century mark a new period in Mexico-U.S. migration. From
2007 to 2016, the estimated number of unauthorized Mexicans in the U.S. declined from 6.95 to 5.45 million.
Mexico-U.S. migration has also changed from a largely circular flow of unauthorized men to a settled
population of families and increasingly authorized migrants. As unauthorized migration from Mexico has
declined, migration from El Salvador, Guatemala and Honduras has steadily increased. From 1990 to 2015,
the number of persons from these three countries resident in the U.S. grew from 975,000 to 3.0 million. The
majority of this migration, like the earlier stages of Mexican migration, is unauthorized. Also similar to the case
of Mexican migration, what started largely as male-led migration has increasingly involved women and
children. The prospect for continued migration from Mexico and Central America remains high. The
Mesoamerican Migration Project will fill an important void in the data available for studying these new migration
flows. The public use data provided by this study can be used to describe, monitor and analyze current
developments and long-term trends in migration, as well as inform new theory with respect to the migration of
children, women and families, and the impact of adverse climatic events, crime and violence. The proposed
Mesoamerican Migration Project builds on many of the core study design features of the NICHD-funded
Mexican Migration Project which conducted household surveys in 174 Mexican communities from 1987 to
2019. It will provide migration data that is comparable across the four countries and backwardly comparable
with four decades of survey data collected in Mexico by the Mexican Migration Project (MMP) and in Central
America by the Latin American Migration Project (LAMP). Innovative features of the Mesoamerican Migration
Project include: a stratified sampling plan that leverages municipal variation in levels of violence and drought;
the use of referral sampling, social media, and telephone interviewing for U.S immigrant samples; parallel
questionnaire content for household heads and spouses; questions on family migration and the migration of
children; questions on multiple border crossings, transit through Mexico, and experiences of abuse; questions
on violence and gang intimidation, crop and livestock loss, and food insecurity; compilation of weather, climate
and homicide data at the municipal level; compilation of Twitter tweets on violence, weather, climatic events
and migrant caravans.

Public health relevance
PROJECT NARRATIVE There are an estimated 11.2 million Mexicans living in the United States, making them by far the largest national origin immigrant group and 25% of all immigrants. The newest sources of large migration from Latin America are the Central American countries of El Salvador, Guatemala and Honduras: from 1990 to 2015 the number of people from these three countries resident in the United States grew from 975,000 to 3.0 million. The Mesoamerican Migration Project will collect survey data in Mexico, El Salvador, Guatemala, Honduras and the U.S. and build on the long-standing NICHD-funded Mexican Migration Project and Latin American Migration Project to provide the most comprehensive dataset for describing, tracking, and explaining current and past migration from Mexico and Central America to the U.S.